Rural-urban and within-rural disparities in Alzheimer's disease and Alzheimer’s disease-related dementias

PROJECT ABSTRACT
This application proposes to examine where and for whom rural residence is associated with Alzheimer’s disease
and Alzheimer’s disease-related dementias (AD/ADRD) in the United States. Analyses will 1) produce novel and
robust estimates of dementia prevalence in rural and urban America; and 2) characterize the types of rural places
and people most affected by dementia. This research is motivated by growing concerns for the health of rural
Americans, roughly 46 million people and 14% of the U.S population. Rural Americans have had poorer health
profiles than their urban peers since at least the 1980s, and the gap has widened over time. Yet surprisingly little
is known about rural-urban disparities in dementia, which is poised to become one of the most significant
population health challenges of the century. Dementia currently affects approximately 6.1 million or 11% of
Americans ages 65 and older, and numbers are expected to rise dramatically in the coming decades due to
population aging. The challenges associated with dementia may be especially severe in rural communities,
where access to quality healthcare and other services for people with dementia and their caregivers is often
severely limited. To anticipate and plan for the challenges associated with dementia, its patterning across places
and people must be understood. However, demographic estimates of dementia prevalence in rural and urban
America are lacking, even at the national level. Moreover, it remains unknown how the prevalence of dementia
varies among rural places and people, despite the fact that rural America is not monolithic. The proposed project
will therefore develop a demographic overview of rural-urban dementia disparities, including novel analyses of
heterogeneity across places (Aim 1) and people (Aim 2). In particular, Aims will explore variation in dementia
prevalence at the intersections of rural residence and regional setting (Aim 1a), county context and composition
(Aim 1b), and individual-level sociodemographic characteristics (Aim 2). Analyses will be conducted with data
from the Health and Retirement Study, a nationally representative survey of older U.S. adults. This application,
led by an early-stage investigator, responds to PAR-23-179, which encourages applications generating scientific
insights about AD/ADRD, including estimates of disparities, from early-stage investigators and established
researchers new to the study of AD/ADRD.

Public health relevance
PROJECT NARRATIVE Rural Americans have had poorer health profiles than their urban peers since the 1980s, and the gap has widened over time. This project will focus on rural-urban and within-rural disparities in Alzheimer’s disease and Alzheimer’s disease-related dementias (AD/ADRD), which in 2020, affected approximately 11% of Americans 65 and older and 35% of those 85 and older. Analyses will 1) produce novel and robust population estimates of dementia prevalence in rural and urban America; and 2) characterize the types of rural places and people most affected by dementia in the United States.